Soft wireless multimodal cardiac implantable devices for long-term investigating heart failure pathogenesis

Project Summary
The goal of this R01 proposal is to develop an ultra-soft, fully implantable, wireless label-free cardiac mapping
and modulation system and apply it to identify chronic electrophysiological and metabolic changes and their links
during heart failure (HF) development, progression, and pacing treatment in unrestrained conscious animals at
cellular and whole heart levels. To achieve this, a miniaturized, mechanically compliant platform that integrates
high-density, high-resolution sensing and modulation channels with wireless energy harvesting, storage, control,
and data communication module is proposed. The resulting systems will greatly reduce motion artifacts and
allow bidirectional high-content electrical and metabolic mapping and pacing in live animals. Those devices are
innovative because they directly address the current limitations in chronically quantifying the individual roles and
interplay between vital cardiac biophysical parameters during heart disease pathogenesis and will be used to
fundamentally investigate the complex disease mechanisms involved in pathophysiological conditions leading to
lethal HF and its therapeutic treatment. Once realized, this technology will be highly valuable to the cardiac
research community. In the long term this work will enable closed-loop multiparametric cardiac mapping and
pacing systems and offer new approaches to study the precise mechanisms and optimize the diagnostic and
therapeutic strategies of other life-threatening heart diseases beyond HF. The three specific aims are:
Aim 1 will establish ultra-soft multimodal cardiac systems for label-free cellular-resolution mapping of the
excitation-contraction-metabolic waves and cardiac pacing. The mechanically compliant highly stretchable
systems consist of high-density arrays (~300 channels in total) of (1) transparent microelectrodes for electrical
mapping and stimulation; (2) multicolor micro-light-emitting diodes, and micro-photodetectors to excite and
measure the autofluorescence of major endogenous fluorescent markers of cellular energy metabolism.
Aim 2 will develop fully implantable wireless schemes for power harvesting, storage, control, and data
communication to chronically operate the platforms in Aim 1 within a closed thoracic cavity in freely behaving
small animals, which is beyond any possibility supported by current techniques. Graphical user interfaces will be
developed for device configuration, real-time bidirectional control, data acquisition and processing. The
integrated systems will be characterized, validated, and optimized by iterative benchtop measurements.
Aim 3 will systematically investigate the precise mechanisms of HF pathogenesis and therapy using a battery
of tests in rat models of HF. The functions of the proposed systems will be assessed in both ex vivo and in vivo
studies. The implantable cardiac devices will identify the individual roles and links between local metabolic and
electrical properties during different time points and stages of HF development and progression, and thoroughly
evaluate the effects of cardiac-resynchronization therapy.

Public health relevance
Project Narrative The research objective of this proposal is to develop ultra-soft, wireless, implantable, cardiac electro-metabolic mapping and pacing systems and apply them to chronically study cardiac electrophysiological and metabolic changes and their links during heart failure development, progression, and termination in unrestrained conscious animals at cell and tissue levels. Our research outcome will advance implantable cardiac devices for unprecedented bidirectional single-cell resolution electrical and metabolic mapping and stimulation of the heart, and identify complex disease mechanisms involved in pathophysiological conditions leading to lethal heart failure and its therapeutic treatment. Our results will greatly facilitate research into the basic operating principles of the heart and the therapeutic outcomes for treating various heart disease-related processes.